EARLY ADVERSE LIFE EVENTS AND MAJOR DEPRESSION

This study will determine whether fluoxetine (antidepressant) reverses the neurobiological consequences of early life stress (e.g., child abuse) and, thus, is effective for treatment and prevention of stress-related syndromal or subsyndromal psychopathology.